Resources and Workforce Development for the Regional Biocontainment Laboratories

ABSTRACT – Overall
Duke University is pleased to respond to RFA-IP-22-075 entitled “Limited Competition: Resources and
Workforce Development for the Regional Biocontainment Laboratories”. Duke is one of 12-NIH funded
Regional Biocontainment Laboratories (RBLs) in the country and has played an instrument role in the world
class translational research being conducted at the DHVI and others throughout Duke and the Research
Triangle region, by providing BSL-3 suites for virology, immunology, microbiology, and animal model services.
Support from this grant will strengthen the overall infrastructure, ongoing facility and equipment maintenance,
establish an enhanced BSL-3 safety and training program, and enhance access to and capabilities of the
existing RBL Research Support services that are located in the BSL-3 environment. The significance of this
grant is that it will allow the Duke RBL to better respond to emerging infectious diseases and play a leading
role in pandemic preparedness. Specific Aims for this proposal are 1) to maintain reliable and uninterrupted
facility functionality; 2) to ensure a safe, secure, and compliant work environment; and 3) provide a state-of-
the-art biocontainment research environment and related support services that enhance the NIAID Biodefense
Facilities Network. This grant will continue to allow Duke to be a crucial resource to a team of internal and
external investigators dedicated to studying and countering select agents and BSL-3/ABSL-3 infectious agents
of global importance.

Public health relevance
NARRATIVE The Duke Regional Biocontainment Laboratory was commissioned in 2007 as a part of a network of 12 RBLs tasked with providing state-of-the-art facilities to aid in the response emerging pathogens and pandemic preparedness. This grant will provide critical support of the RBL operational infrastructure, comprehensive training program, and enhancement of Research Support services.